PHARMACOKINETIC ASSESSMENT OF THYROGEN IN PT WITH THYROID CANCER

The purpose of this phase II study is to determine the pharmacokinetic profile of thyrogen, recombinant, human thyroid stimulating hormone (RHTSH) when administered to thyroid cancer patients.